Novel Pathogenic Mechanisms of Joubert Syndrome

ABSTRACT
Inherited retinal degeneration is a leading cause of irreversible blindness in children. There is currently no
effective therapy for any of these diseases except RPE65. The systemic manifestations of the syndromic forms
of ciliary degeneration make them a particularly challenging form of the inherited retinal degeneration family to
treat. Joubert syndrome is a rare inherited form of retinal degeneration in which patients die prematurely and
which has specific defects localized to the connecting cilium of photoreceptors. ARMC9 is a recently
discovered gene that has been implicated in Joubert syndrome. This application seeks to identify the
mechanism underlying the interplay between the loss of ARMC9 and impaired mitochondrial function in cilia
formation. We have strong preliminary data supporting a novel link between mitochondrial function and
ciliogenesis. We hypothesize that augmentation of mitochondrial function in ARMC9 mutations will rescue the
loss of function. We aim to (1) dissect the mechanism by which mitochondrial proteins contribute to ARMC9
localization, (2) determine whether NMNAT overexpression rescues the loss of ARMC9, (3) determine whether
CRISPR-mediated gene editing of ARMC9 restores photoreceptor formation in human iPSC-organoids. These
studies will further our understanding of mitochondrial and ciliary function and facilitate the discovery of new
therapies for ciliary disorders, including photoreceptor degeneration.

Public health relevance
NARRATIVE Retinal degeneration is a leading cause of blindness. We have discovered a novel link between mitochondrial defects and disrupted cellular cilia in Joubert syndrome, a rare form of retinal degeneration in children. The proposed studies will restore the function of mitochondria and cilia; we anticipate that they will lead to new therapeutics for this blinding disease and for other more common forms of retinal degeneration.